Administrative Core

RCA PROJECT SUMMARY
The overarching goal of our P01, Deploying High Value Longitudinal Population-Based data in Dementia
Research (DEVELOP AD RESEARCH), is to create an integrated program of research that considers the
wider medical, health system, and social contexts of dementia that are important to patients and families and
that have been inadequately considered in prior research. Our specific focus is on research questions that
demand the use of population-based data resources and cannot be addressed by more mechanistically
focused studies in a timely or cost-efficient manner. The P01 supports research that: a) examines the complex
interaction of dementia and other serious illness; b) identifies the impact of clinical and social disruptive events
on disease trajectory and outcomes; c) explores medication prescribing in the context of dementia; and d)
examines how models of community-based care (hospice and home-based medical care) meet the needs of
people with dementia and their families over the duration of illness. Leveraging our track record conducting
groundbreaking research employing the rich, comprehensive, and longitudinal data of the HRS and NHATS,
we will create the knowledge needed to enhance quality of life for persons with dementia and their caregivers.
RCA will provide coordination and oversight of the P01 as well as the vision and leadership needed to
advance and to translate our research findings into improvements in care. The specific aims of RCA are:
· SA 1: To support scientific innovation for older adults with dementia by ensuring regular, ongoing
coordinated scientific interaction, planning, learning and feedback between all cores and projects, and
effective use of shared resources with optimal efficiency;
· SA 2: To provide day-to-day management, including the preparation of administrative documents;
management of fiscal matters of all projects and cores including oversight of all budgets, resources, and
sub-contracts; and manage data use agreements, data security, human subjects review;
· SA 3: To monitor research progress, implement necessary remediation, and ensure timely publication and
dissemination of research findings;
· SA 4: To leverage our national roles in the OAIC Network and National Palliative Care Research Center to
disseminate our findings, resources, and programming codes and provide “office hours” and resources to
early stage investigators across the nation engaged in population-based research programs in dementia.
RCA advances population-based research in dementia and its translation into clinical practice through a
comprehensive framework of coordinated activities. This framework provides infrastructure for research,
nurtures and facilitates collaboration, promotes the use of cutting-edge methodologies, and disseminates
results to the scientific and policy communities. RCA also incorporates an innovative focus on career
development for early stage investigators and promotes the use of HRS and NHATS for dementia research.